Novel Materials and Methods for Separations of Glycopeptides and Glycans

DESCRIPTION (provided by applicant): Analysis of glycoprotein polypeptide sites of carbohydrate attachment and the structures of the glycans present on these proteins requires the combination of high resolution chromatographic separations and sophisticated mass spectrometry. Hydrophilic interaction liquid chromatography (HILIC) has great use in separations of glycopeptides and released glycans, exhibiting remarkable selectivity for the separations of glycoforms. The proposed effort is to markedly improve separations of glycopeptides and released glycans by HILIC, reducing the separation times from the current 2-3 hours per sample, to 30 minutes or less. The separations component of LC/MS analysis of glycoproteins can benefit from the design of more efficient stationary phase chromatographic materials, and from the use of conditions that allow direct and productive interfacing with mass spectrometers. We propose that recently developed superficially-porous silica microparticulate silica packing materials (Fused-Core(R) structures) can achieve these separation speeds, without loss of the required high resolution. The AMT Fused-Core reversed phase materials have previously been shown to exhibit superior kinetic properties and column efficiencies for separations of small molecules, and recently, wider pore size packings have shown a similar benefit for larger peptides (c. 3-5 kDa). The current proposal uses Fused-Core technology with unique surface modifications to develop high performance HILIC materials specifically for separations of glycopeptides and glycans. Tailored HILIC materials will be synthesized and tested for HILIC operation, as well as to establish the fundamental relationships between surface properties, particle characteristics, and utility for glycan and glycopeptides separations. The new bonded phases utilize organosilane chemistry discovered in Phase I efforts that have been selected to withstand aggressive conditions of use, permitting stable and robust separations materials that can be used across a broad range of conditions. Preliminary LC/MS applications in glycoproteomic applications have been completed in Phase. A reasonable estimate is that an improvement of >2-fold for separations times are obtained. Phase II will expand on this effort, with the purpose of delivering further improved materials and methods to a broader range of needs in glycoproteomics and proteomics workflows. A significant aspect of the current proposal will assess the benefits and real-world applications of these new separations materials. The target of this work is to produce robust materials that permit simple integration with online mass spectrometry analysis, effective for resolution of the complex mixtures that are typical of current glycoprotein identification and structural characterization procedures.

Public health relevance
PUBLIC HEALTH RELEVANCE: Protein modification by the addition of sugars (called glycosylation) is extremely common in nature, and this modification exhibits a strong effect on protein structure and on biological function. In certain diseases, most notably in cancer and for some infectious diseases like influenza, glycosylation of proteins, or recognition of such proteins, is altered in ways that are not fully understood. In some cases these alterations are big enough to allow them to be used for recognition of disease, and in some cases to stratify patients. The current proposal is to use new knowledge in materials science and chemistry to enable much faster and more efficient ways to discover glycosylation disease markers and to better understand the biology of glycosylation. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Analytical tools for the determination of protein glycosylation state, definition of glycan structures, and site of glycosylation continue to develop at the expense of increasing time, cost and complexity of analyses. This trend is particularly true for analyses of glycans in complex mixtures of proteins, so-called glycomic or glycoproteomic experiments. High pressure liquid chromatography (HPLC) separations of glycopeptides and glycans, combined with sophisticated mass spectrometry (MS) methods, have emerged as a method of choice to enable informative and rapid analyses of protein glycans. The goal of the proposed effort is to improve hydrophilic interaction liquid chromatography (HILIC) HPLC column packing materials for separations of glycopeptides and released glycans. These novel materials will utilize newly developed silica nanoparticle technologies, combined with directed design of stable and robust surface chemical modifications. The design, synthesis and characterization activities will be specifically oriented to meet the desire to accelerate the throughput of HILIC HPLC and HPLC/MS workflows required for glycopeptide and glycan identification and characterization. As part of the Phase I activities, useful technology towards this end has been accomplished. At the completion of Phase I an improvement of greater than about 2-fold for time to analyze complex samples was achieved, and for simpler samples, well greater than 2-fold was achieved. Technologies for improvement by a significant factor, perhaps an additional 2-fold or more have been uncovered. Moreover, additional opportunities in glycoproteomic and proteomic workflows have become apparent. Successful outcomes of this work include; 1. A series of new HILIC bonded phase materials will be created, allowing relationship(s) between polarity, pore size, shell thickness, retention, efficiency and separation speed for targeted molecules to be revealed. 2. Targeted improvements in surface modification and particle characteristics will result in specific improvements for speed and efficiency of glycan, glycopeptide and peptide separations by HILIC by an additional 2-fold over those achieved in Phase I. 3. Throughput for glycopeptides and glycan separations increase by >4-fold, as measured with meaningful examples of released glycans by analysis of complex glycoform mxitures, determined for glycoproteins and glycoprotein mixtures. 4. New FusedCore HILIC columns for high performance applications with broad applications in glycoproteomic and proteomic workflows are delivered to the market. Accomplishing these outcomes will deliver new knowledge and novel technology to proteomics and glycoproteomics that significantly improves time to answer, and permits higher throughput experimental designs. The results of the Phase II effort are intended to directly improve a product delivered by Phase I results, and to expand the technical and commercial reach these novel technologies. Our ultimate goal will be to deliver viable high performance separations products that enable the glycoproteomics and proteomics fields by meeting corresponding technical and market needs.